EphB/EphrinB signaling in Systemic Sclerosis

Project Summary
This proposal identifies the EphB2 receptor tyrosine kinase and its cognate EphrinB ligands as potential
therapeutic targets to prevent vascular damage and fibrosis associated with systemic sclerosis (SSc, also
known as scleroderma). A hallmark of SSc is the progressive and overwhelming deposition of extracellular
matrix components, especially collagen, to cause the skin to become fibrotic and lose its elasticity. This
process is thought to be driven by the recruitment of immune cells to sites of tissue damage, providing an
inflammatory microenvironment to enhance fibroblast-to-myofibroblast transitions that in SSc patients leads to
pathological expansion of pro-fibrotic cells and massive upregulated expression of collagen and other genes
involved in fibrosis. As the biochemical pathways that control these events remain incompletely described, we
focused our attention on potential membrane-associated molecules that may help interpret extracellular signals
and aid the conversion of dermal fibroblasts into fibrogenic myofibroblasts, and identified the EphB2 receptor
interacting with its EphrinB ligands as possible important components. Emerging data support the involvement
of EphB-EphrinB in fibrosis of multiple organs, including our previous work, however little is known about the
potential role of these highly conserved signaling molecules in the pathogenesis of SSc. Using human skin
biopsies and mouse models of skin fibrosis, we will test the hypothesis that upon chronic, immune-mediated
skin injury, EphB2 expression becomes strongly upregulated and the enhanced signaling pathways activated
by this molecule are critical for the transdifferentiation of quiescent dermal fibroblasts into fibrogenic
myofibroblasts to help bring about skin fibrosis. Our general idea is that when bound to EphrinB ligands
expressed on various cells of the injured skin microenvironment (including endothelial cells), activated EphB2-
expressing fibroblasts will initiate a differentiation process leading to their transformation into pro-fibrotic
myofibroblasts. In support of this, preliminary data is provided that shows EphB2 expression is highly
upregulated in human skin from SSc patients and in normal human dermal fibroblasts exposed to the pro-
fibrotic inflammatory cytokine TGF-β1, and that skin fibrosis can be modulated by disrupting EphB2 either
through genetic mutation or novel pharmacological approaches. The preliminary data has guided the
formulation of three Specific Aims that will further test our ideas. Aim 1 will determine whether activation of
EphB2 forward signalling is required for the progression of skin fibrogenesis. Aim 2 will test the hypothesis that
EphB2-EphrinB interactions and signaling contributes to vascular damage and defective angiogenesis in SSc.
Finally, Aim 3 will determine whether therapeutic targeting of these molecules will mitigate skin fibrosis. The
proposed research is highly significant and innovative as it will reveal a key molecular mechanism that drives
excessive fibrosis in SSc, and will also provide important early data on how novel small molecules that target
EphB2-EphrinB interactions and signaling could be employed as future therapies to treat SSc.

Public health relevance
Project Narrative Scleroderma is a chronic autoimmune disease characterized by overproduction of collagen leading to fibrosis of skin and internal organs. The work proposed will test the hypothesis that the EphB2 receptor tyrosine kinase is critical for the development of SSc fibrogenesis and has the potential to provide a novel therapeutic approach that could ultimately be used to combat this disease.